Mechanisms of Auditory Circuit Development

PROJECT SUMMARY
The long-term goal of my laboratory is to elucidate the mechanisms that regulate auditory perception, and how
defects in hair cells and auditory neurons cause disease. We propose here to study the mechanisms that regulate
the differentiation, connectivity and function of spiral ganglion neurons (SGNs). Our central hypothesis is that
SGNs are a diverse group of neurons with different connectivity patterns and functions, and that diversification
of SGNs and their connectivity depends on signals provided by hair cells. To test our hypothesis, we will combine
studies in genetically modified mice with histology, imaging, genomics, electrophysiological and hearing tests to
study SGN connectivity and function. We will map SGN projection patterns, define how mutations linked to
deafness affect SGN differentiation and projection patterns, and use genetic manipulations combined with
electrophysiology and genomic tools to identify signals initiated by hair cells that affect SGN differentiation. Our
preliminary data show the feasibility of our approach, demonstrating that SGNs are a molecularly diverse group
of neurons with different projection patterns and that defect in hair cells affect SGN differentiation. We anticipate
that our findings will define mechanisms by which hair cells affect SGNs to regulate their diversification into
subtypes with different functions and connectivity patterns.

Public health relevance
PROJECT NARRATIVE Hearing loss is a major health problem that significantly affects the life quality of affected individuals. Many forms or hearing loss are caused by defects in auditory hair cells and the neurons that innervate them. We propose here to study the mechanisms that regulate the connectivity of spiral ganglion neurons that innervate hair cells, and how they are affected in a genetic form of hearing loss with the anticipation that our studies will ultimately lead to a better treatment of the disease.